The effects of APOE4 on carnitine/acylcarnitine mediated bioenergetic deficits in Alzheimer's disease

Alzheimer’s disease is a neurodegenerative condition which affects 50 million people worldwide. It is
increasing being recognized that, in addition to amyloid and tau, there are other factors which contribute to the
complex and heterogenous etiology of AD. In that regard, recent investigations show that brain bioenergetic
deficits and abnormal lipid metabolism alter the brain’s milieu, making it more susceptible to age-related insults
and thereby increasing the brain’s vulnerability to developing AD. Carnitine and acylcarnitines are critical for
central nervous system (CNS) bioenergetics due to their role in fatty acids oxidation in mitochondria for the
brain’s energy requirements. Bioenergetic deficits are observed at an early age in subjects with the
apolipoprotein E (APOE) ε4 allele, which is the most important genetic risk factor for majority of late-onset AD
cases. The proposed work will explore the influence of APOE ε4 in carnitine- and acylcarnitine-mediated
bioenergetic deficits in the pathogenesis of AD.
We recently observed that carnitine, a carnitine metabolite trimethylamine N-oxide (TMAO) and
acylcarnitine levels are altered in the blood and brains of AD patients. We also show that ε4 carriers at
preclinical or early stages of AD have elevated levels of TMAO. Elevated medium chain acylcarnitine (MCA)
were detected in the brain and blood of ε4 carriers, reflecting an incomplete fatty acid oxidation. These data,
together with the existing evidence of glucose hypometabolism in the brains of ε4 carriers, suggest that
bioenergetic deficit may be an early event in AD. We therefore hypothesize that APOE ε4 dependent deficits in
the transport of peripheral carnitine and acylcarnitines to the brain and in their metabolism in the periphery or in
the brain contribute to the brain bioenergetic deficits which make the brain vulnerable to AD pathology. We will
first characterize abnormal carnitine and acylcarnitine profiles in the brain and blood of neuropathologically
diagnosed AD patients and in AD mouse models to examine the influence of APOE genotypes on the
relationship between carnitine/acylcarnitines and AD. We will examine if peripherally administered stable
isotope labeled carnitine and acylcarnitines are differentially transported and metabolized in an AD mouse
model with 5 x AD mutations and with genetic targeted replacement of murine APOE with human APOE
isoforms (EFAD mice). We will also determine whether these changes occur prior to or with the onset of
amyloid and tau pathologies. These studies will clarify whether APOE ε4 contributes to both transport and
metabolism deficiencies of peripheral carnitine and acylcarnitines and identify new avenues for developing
treatment strategies for AD, particularly for ε4 positive individuals who are at a high risk of developing AD.

Public health relevance
Late onset Alzheimer’s disease (AD) affects nearly 6 million Americans and the apolipoprotein E (APOE) ε4 allele is the most common genetic risk factor for this condition. To date, AD remains an untreatable condition, and while billions of dollars have been invested on finding disease-modifying drugs that target key hallmarks of AD, such as amyloid, many of these drugs have been unable to substantially reduce cognitive decline in AD patients, suggesting the presence of other biological factors that also contribute to the complex etiology of AD. Therefore, we will target the brain’s energy generation process associated with carnitine/acylcarnitine transport and metabolism as a novel approach in identifying therapies for AD and specifically focus on APOE ε4 positive subjects who are highly susceptible to developing AD.